The GCE4All Center: Unleashing the Potential of Genetic Code Expansion for Biomedical Research

The proposed GCE4All Biomedical Technology Development and Dissemination Center at Oregon State
University (OSU) will optimize, develop, and broadly disseminate Genetic Code Expansion (GCE) technology –
the engineering of cellular translation to express proteins containing non-canonical amino acids (ncAAs). GCE
provides unprecedented ways to probe and manipulate macromolecular structure and function, analyze protein
malfunctions in disease, engineer bioanalytical tools, and create new precision biotherapeutics. GCE's feasibility
is well-established, but it remains difficult for researchers to access and implement, and thus remains little-used
– an ideal target for BTDD support. During its envisioned lifespan of ≤15 years, the Center's mission will be to
optimize and extend existing GCE technologies to enable facile use by non-specialists, and to broadly disseminate
them via widespread education, effective training, and by providing sustainable access to optimized technologies
via established repositories – enabling powerful GCE approaches to become standard, widely-used tools of
biomedical researchers. Advantageous for creating the proposed Center is our experience and leadership in the
groundbreaking predecessor OSU Unnatural Protein (UP) Facility (2012-21), which at a much smaller level
developed and disseminated GCE methods and trained researchers. GCE4All Center leaders are thus well-
equipped to accomplish the Center mission via its 2 Technology Development Projects (TDPs), 10 initial Driving
Biomedical Projects (DBPs), and Community Engagement (CE). The synergistic TDPs will optimize and extend
GCE methods for 1) bioorthogonal ligation applications using GCE-produced proteins, including low-
background labeling and tracking in mammalian cells, and 2) producing ncAA-proteins that contain biochemical
probes and/or native or analog post-translational modifications (PTMs) – ubiquitous but little-understood
regulators of protein functions. To ensure broad relevance, targeted technology advances will overcome barriers
faced by geographically-diverse, NIH-funded DBPs that will serve as stringent testbeds for the work. To achieve
its “GCE for All”goal, Center optimizations will bridge 4 common technological barriers that deter researchers
from adopting GCE. These 4 GCE Bridges include: effective tools for 1) incorporating ncAAs of choice; for
efficiently producing impurity-free GCE proteins in 2) E. coli and 3) mammalian cells; and 4) creation of stable
mammalian cell lines and reliable protocols for reproducible studies in cells. The CE core will provide diverse
training activities including hands-on workshops already proven effective by our UP Facility. Via the Center
website, CE will disseminate GCE methods, online training, and host a Wiki GCE-knowledgebase and a GCE4All
community networking bulletin board enabling peer-to-peer support in the GCE user community. The CE core
will also organize biennial International GCE Conferences and ensure all optimized reagents are publicly
available from repositories. The GCE4All Center will achieve these ambitious goals in Years 1-5, toward its
ultimate goal of transforming GCE from a boutique method to a standard part of the molecular biologist's toolkit.

Public health relevance
Narrative for Genetic Code Expansion Center The Genetic Code Expansion Biomedical Technology Development and Dissemination Center will allow biomedical researchers around the world to have access to better scientific tools to generate specially designed forms of proteins for probing and visualizing how life works. This will help them better determine how and where biological processes go wrong to cause cancer, heart disease, pain, diabetes, Parkinson's disease, and many other diseases, and will also drive new innovations and enable the development of more sensitive and specific diagnostic tests and more effective drugs.